Environmental Factors Predicting Risk of Severe COVID Infection

Project Summary/ Abstract
The objective of this project is to identify the effect of air pollution on the risk and severity of
COVID-19 illness. Air pollution may increase the risk of viral infections of the lung in general
and there is emerging evidence that COVID-19 illness may be increased in regions where air
pollution levels are high. Identification of factors that increase risk of COVID-19 illness will have
major public health impacts. We will assess the incidence, prevalence and severity of COVID-19
infection within COPDGene, a well-characterized, longitudinal cohort of subjects with and
without existing lung disease. The cohort is distributed at 20 clinical centers across the United
States and includes subjects with a broad distribution of socioeconomic characteristics, rural
and urban locations and air pollution exposures. The cohort was enriched for African-American
subjects. We will adjust for other socioeconomic factors in the models using county level
census data and normalize the cohort data to county level disease prevalence. Longitudinal
analyses of COVID-19 incidence in relation to changing levels of monthly air pollution will be
done and the impact of pre-existing lung disease on the outcomes will be studied. The air
pollution data will be based on spatial analysis of the cohort using satellite and ground
monitoring measures of particulates, NOx, SO2, CO and ozone, to identify factors that modify
risk of: any disease, severe disease or death. The impact of air pollution on lung structural
damage after COVID-19 illness will be measured using pre and post-COVID chest CT scans and
spirometric changes in the cohort to identify extent of lung involvement and persistent effects.

Public health relevance
Project Narrative: Air pollution may play a role in transmitting viral infections including COVID-19 illness and may also worsen the disease severity or long term effects of a viral infection on the lung. This project proposes to study the risk of COVID-19 infection using spatial data to identify local air pollution as a risk factor for disease. The project will also measure the damage to lung structures after COVID-19 illness, related to varying amounts of air pollution.